Factors of Resilience to Alzheimers Disease and Related Dementias among Latinx: The Role of Bilingualism

Project Summary/Abstract
As the population ages, Latinx communities, families, and healthcare systems will be confronted by the
growing crisis of Alzheimer’s disease and related dementias (ADRD). Identifying factors that confer resilience
to ADRD among aging Latinx communities is of critical importance to successfully reduce disparities. Some
studies find that bilinguals are at reduced AD risk compared to monolinguals, but other studies do not find
evidence of a bilingual advantage. Little attention has been given to within-group differences among bilinguals,
such as age of second language (L2) acquisition, proficiency, and frequency of language use, and how these
differences 1) are related to cognitive function in older age, 2) if they buffer the effects of neuropathology on
cognitive decline, and 3) how cognitive decline in AD can influence language use among bilinguals.
Determination of the aspects of bilingualism that confer resilience to AD could lead to novel interventions to
mitigate cognitive aging and ADRD disparities. The overall aim of this project is to determine whether aspects
of bilingualism, including age of acquisition, language use, and proficiency, buffer the effects of neuroimaging
markers of pathology (i.e., AD biomarkers and cerebrovascular disease) on cognition and cognitive decline
within middle- and older-aged Latinx adults. The K99 phase of this study showed that earlier age of acquisition,
greater L2 proficiency, and greater daily bilingual language use, but not increased code-switching, were
positively associated with episodic memory, language abilities, and aspects of executive functioning,
independent of confounding sociocultural factors (i.e., education, socioeconomic status, immigration). In the
R00 phase, the relationship between bilingualism and imaging markers on cognitive decline will be evaluated
(Aim 1) and we will evaluate whether change in cognitive status is associated with longitudinal changes in
bilingualism (Aim 2). The proposed study will harmonize data from Latinx adults currently enrolled in three
longitudinal cohorts with available amyloid and tau PET, MRI, and cognitive assessments: the Offspring study
and the Washington Heights-Inwood Columbia Aging Project at Columbia University, and the University of
California-Davis Diversity Aging Cohort. To accomplish these goals, the applicant has built on his strengths in
cultural neuropsychology, health disparities, and statistical methods through the training obtained during the
K99 phase focused on 1) expanding knowledge of the cognitive neuroscience and psycholinguistics of
bilingualism; 2) modeling neuroimaging data; 3) the operationalization and measurement of resilience among
aging Latinx populations; and 4) enhancing statistical methods focused on data harmonization, casual
inference methods and latent variable modeling. This R00 proposal lays the foundation for an independent
research career focused on mechanisms underlying the protective factors of bilingualism in cognitive aging.

Public health relevance
PROJECT NARRATIVE. Latinx are at increased risk for Alzheimer’s disease and related dementias (ADRD) compared with non- Hispanic whites. Bilingualism may reduce ADRD risk but prior studies lack detailed characterization of within- group differences among bilinguals such as age of second language (L2) acquisition, L2 proficiency, and frequency of dual language use and its relationship to cognition in the presence of neuropathology. The current study will elucidate mechanisms underlying the relationship among bilingualism, neuroimaging markers of pathology, and cognitive function, which has the potential to inform novel interventions to preserve cognitive function and reduce ADRD disparities.